ION TRANSPORT BY COLON AND HORMONAL CONTROL

The sodium and potassium content of human body fluids is maintained through active absorption or secretion of these ions by epithelial tissues like the colon and distal renal tubule. Alterations in electrolyte balance brought about by circulating hormones, pathological states, or drugs reflect the actions of these agents on specific transport processes in the apical and basolateral membranes of epithelial cells. In order to understand the cellular mechanisms underlying epithelial transport and its regulation it is necessary to employ model systems which may be isolated from the organism and studied under conditions where the driving forces for mass transport can be readily manipulated. In addition it is essential to develop methods which permit the individual properties of apical and basolateral membranes to be discerned. The object of the proposed research is to identify the ion transport elements in the apical and basolateral membranes of epithelial cells, to investigate the mechanism of ion translocation through these elements, and to determine what cellular factors regulate ion traffic through specific elements. We will employ two model systems, the large intestine of the turtle and the urinary bladder of the winter flounder, which may be conveniently studied in vitro. We will employ techniques which enable us to "functionally isolate" individual transport elements in the intact epithelium so that their properties may be studied directly using electrophysiological and radioisotope techniques which are well established in our laboratory. We will attempt to develop a preparation of isolated colonic cells which will permit us to study the relation between plasma membrane transport and cell composition. In addition we will attempt to isolate plasma membrane fractions which are enriched in apical and basolateral membranes so that transport elements can be isolated in membrane vesicles and, ultimately, reconstituted in liposomes or lipid bilayers. This three-pronged approach will enable us to trace the properties of individual transport elements through successive stages of purification and ultimately to obtain an integrated description of the cellular transport of sodium and potassium and the regulation of these processes under normal conditions as well as in pathologic states.